NIDA DEVELOPMENTAL STUDIES BIOREPOSITORY AND ANALYSIS CENTER. SEPTEMBER 17, 2021 - SEPTEMBER 16, 2022. N01DA-21-5588. TASK ORDER 75N95021F00001 (TO1).

NIDA DEVELOPMENTAL STUDIES BIOREPOSITORY AND ANALYSIS CENTER